mDOT TR&D2 (Optimization): Dynamic Optimization of Continuously Adapting mHealth Interventions via Prudent, Statistically Efficient, and Coherent Reinforcement Learning

Project Lead: Murphy, Susan Principal Investigator: Kumar, Santosh
TR&D2: Dynamic Optimization of Continuously Adapting mHealth Interventions via Prudent,
Statistically Efficient, and Coherent Reinforcement Learning
Lead: Dr. Susan Murphy, Harvard University; 10% effort (1.2CM)
Abstract: The mHealth Center for Discovery, Optimization & Translation of Temporally-Precise Interventions
(the mDOT Center) will enable a new paradigm of temporally-precise medicine to maintain health and manage
the growing burden of chronic diseases. The mDOT Center will develop and disseminate the methods, tools,
and infrastructure necessary for researchers to pursue the discovery, optimization and translation of temporally-
precise mHealth interventions. Such interventions, when dynamically personalized to the moment-to-moment
biopsychosocial-environmental context of each individual, will precipitate a much-needed transformation in
healthcare by enabling patients to initiate and sustain the healthy lifestyle choices necessary for directly
managing, treating, and in some cases even preventing the development of medical conditions. Organized
around three Technology Research & Development (TR&D) projects, mDOT represents a unique national
resource that will develop multiple methodological and technological innovations and support their translation
into research and practice by the mHealth community in the form of easily deployable wearables, apps for
wearables and smartphones, and a companion mHealth cloud system, all open-source.
Technology Research and Development project 2 (TR&D2) will address three key limitations of current online
reinforcement learning (RL) when applied to personalize mobile interventions to individuals. Two of these
limitations are related to the need to increase efficacy and reduce negative delayed intervention burden effects
leading to disengagement. The third looks to future needs involving the personalization of multiple intervention
components each operating at a different time scale. In particular, we will accommodate the ever-present mobile
health challenge of user disengagement by developing a continuum of approaches between RL algorithms that
ignore delayed intervention effects and RL algorithms that attempt to capture noisy delayed intervention effects
over a more distant future. Second, we will increase the rate at which personalization occurs via optimally
leveraging data across time and across users to more quickly personalize the interventions to each user. Third,
we will develop the first RL approaches to coherently personalize multiple intervention components holistically.
In addition, to enhance impact and dissemination, the methods will be developed in close collaboration with three
collaborative projects with an emphasis on model interpretability. We will provide the two service projects and
the broader research community with open-source software tools and systems consisting of smartphone and
cloud computing components for online personalization. TR&D2 will synergistically work in partnership with the
other TR&D projects, the Training and Dissemination Core, and the Administration Core to maximize the societal
impact of TR&D2 technologies.
0

Public health relevance
Project Lead: Murphy, Susan Principal Investigator: Kumar, Santosh TR&D2: Dynamic Optimization of Continuously Adapting mHealth Interventions via Prudent, Statistically Efficient, and Coherent Reinforcement Learning Lead: Dr. Susan Murphy, Harvard University; 10% effort (1.2CM) Public Health Relevance: TR&D2 will take advantage of the recent developments in wearable and sensor technology to provide precision interventions to individuals at optimal times and locations so as to provide maximal health benefit. TR&D2 will thus enable a new, powerful approach to personalizing mobile health interventions, enabling patients to initiate and sustain the healthy lifestyle choices necessary to prevent and/or successfully manage the growing burden of multiple chronic conditions. 1